San Antonio Nathan Shock Center of Excellence in the Biology of Aging

The purpose of this administra�ve supplement is to request funds to purchase the latest version
of CLAMS Comprehensive lab animal system, which will further improve the services provided by
Integrated Physiology of Aging Core (IPAC) of the Nathan Shock Center (NSC) in San Antonio. The
IPA core has been a part of the NSC for more than 29 years to support the overall mission of the
San Antonio Nathan Shock Center to enable research that aims to expand our understanding of
mechanisms of aging and of age-associated disease. The IPA core will provide intellectual and
instrumental/technical services to the scien�ﬁc community on the selec�on and performance of
func�onal assays in rodents that aim to increase our knowledge about mechanisms that control
age-related changes in func�on at the �ssue, organ, and whole-body levels, in the context of
normal aging and in rela�on to age-related diseases. We provide exper�se and assistance to
inves�gators with an interest in aging-related ques�ons in the design and execu�on, as well as
data analysis and interpreta�on on experimental measures. Of all the services oﬀered, the
metabolic analysis of aged mice, in response to therapeu�cal interven�on, is an indispensable
component in the IPA core. For the metabolic analysis, a CLAMS Comprehensive lab animal
system can be used to monitor water consump�on, food intake, locomotor ac�vity, O2/CO2 and
energy expenditure, crucial parameters to represent the healthspan in aged mice. With this key
piece of equipment, the service quality in IPA core will be greatly enhanced. Thus, the request for
addi�onal new equipment conforms to the stated purpose of suppor�ng and enhancing shared
resources and facility for categorical research by a number of inves�gators from diﬀerent
disciplines. The integra�on of the San Antonio IPA Core with other programs to study mechanisms
of the aging process has been an obvious beneﬁt to these studies. The incorpora�on of a highly
advanced CLAMS Comprehensive lab animal system will allow us to provide service to monitor
healthspan in diﬀerent species during aging and by various interven�ons.
Project summary /Abstract

Public health relevance
The Integrated Physiology of Aging Core (IPA) has been a part of the NSC for about 29 years to a) provide services to local, na�onal, and interna�onal inves�gators to characterize the physiological changes in animal models (mice, rats, naked mole-rats, and non-human primates) of aging, and b) examine the eﬀects of various interven�ons (dietary, gene�c, and pharmacological) on age-related physiological changes, including metabolism and behavior. The services of the IPA Core are available to and have been used by inves�gators from the other cores of the San Antonio NSC, the Interven�on Tes�ng Program, San Antonio, Pepper Center, other departments at UT Health, and at other academic ins�tu�ons in the United States. The IPA Core provides inves�gators with services in aging animal models (mice, rats, naked mole-rats, and non- human primates) and makes the resul�ng data widely available to the scien�ﬁc community Project Narra�ve